Dominance on the Human Genome and Non-additive Polygenic Models for Predicting Complex Traits

Project Abstract
Dominance is one of the most fundamental concepts in genetics and has many key implications in population
genetics, as it ultimately determines how selection manifests in a population. However, despite its unarguable
importance, dominance is also one of the least characterized quantities in genetics, especially in humans, with
the major challenge being current methods cannot distinguish dominance from the fitness effect of genomic
variants. This proposed K99/R00 work will systematically address this longstanding problem from a dual-
perspectives, by inferring dominance in humans and quantitatively model its role in shaping the phenotypes of
complex traits and diseases. Specifically, in Aim1, I will develop a powerful machine learning-based method to
infer the realistic distribution of dominance on the human genome in megabase-scale, leveraging archaic
introgressed ancestry in non-African populations that is sensitive to dominance variation in genomic regions. In
Aim 2, I will develop non-additive polygenic models accounting for dominance in full genomic regions to identify
complex traits profiled in UK Biobank that deviate from additive models, improve the accuracy of phenotype and
disease risk predictions, and contribute to an in-depth understanding of complex trait biology. Finally, in Aim 3
(R00 phase), I will extend these approaches to infer dominance variation in worldwide populations and
investigate how dominance, combined with selection and admixture, determines complex trait phenotypes in
diverse human populations. The mentored phase of this work will take place at the Department of Ecology and
Evolutionary Biology at UCLA, where Dr. Zhang will have access to rich training opportunities and be supported
by active scientific communities, including numerous seminar series, journal clubs, and networking activities. Dr.
Kirk Lohmueller (primary mentor) and Dr. Sriram Sankararaman (co-mentor) will train Dr. Zhang in computational
and statistical methods in population genetics, machine learning applications, and large-scale disease
association data analysis. The research trainings, collaborations, and professional development during the K99
phase will assist Dr. Zhang in becoming an independent investigator in human population genetics.

Public health relevance
Project Narrative Dominance plays a vital role in human evolutionary genetics both in terms of its fitness effect on functional genomic variants and how it shapes complex trait phenotypes, while its distribution on the human genome and biological effects on complex traits are poorly characterized. This work will fill a critical knowledge gap by producing a complete picture of dominance distribution in humans, which will shed a light into many unsolved questions in genetics, including the evolution of dominance. This work will further provide comprehensive statistical frameworks to model the relationship between dominance and complex trait phenotypes, which will substantially improve the transferability of biomedical applications in historically understudied populations, including disease risk prediction and the development of precision medicine.